Investigating the Role of the Dorsal Hippocampus to Nucleus Accumbens Pathway in Regulating Social Interaction

Abstract
Major Depressive Disorder (MDD) is a major public health problem across the globe. Despite growing
awareness and treatment, existing antidepressant therapies often leave patients with residual symptoms.
Moreover, some of the most debilitating symptoms of MDD, such as impaired social interaction, lack specific
pharmacologic therapies entirely. Targeting these symptoms could improve outcomes not only in MDD, but
also in other disorders where social interaction is affected, such as Autism Spectrum Disorder.
Hyperpolarization-activated cyclic nucleotide-gated (HCN) channels have recently been identified as a
possible therapeutic target for the treatment of behavioral changes related to chronic stress. These
nonspecific cation channels play a role in regulating neuronal excitability. Antagonizing HCN channels in the
dorsal hippocampus (dHC) promotes excitability and limits behavioral changes in response to chronic stress
in animal models. However, the dHC is mostly known for its role in spatial navigation and early investigators
did not find evidence of projections from the dHC to brain regions involved in the regulation of behaviors that
are affected by chronic stress. As such, it remains unclear why altering dHC excitability through
changes in HCN channel expression would influence animal behavior.
Recent work has emphasized the role of a projection from the dHC to the nucleus accumbens (NAcc)
in the regulation of motivated behavior to a sucrose reward. Unlike the dHC, activity in the NAcc has
previously been shown to influence social interaction behavior. As a result, we hypothesize that the dHC
to NAcc projection plays an essential role in regulating social interaction and we will investigate this
hypothesis in two aims. In Aim 1, we will perform fiber photometry (FP) in order to study the activity of
projections from the dHC to the NAcc. These experiments will utilize animals subjected to chronic social
defeat (CSD), a chronic stress paradigm that leads to impaired social interaction behavior in a subset of mice
(termed ‘susceptible’ mice). In Aim 2 we will utilize a novel viral approach to enhance cellular excitability in
the dHC to NAcc pathway in order to try and rescue social interaction behavior after CSD in susceptible mice.
We predict that by altering the excitability of the dHC to NAcc pathway, we will be able to rescue the
behavioral changes that occur following CSD. These experiments will help define a new function of the dHC
in health and in response to chronic stress.

Public health relevance
Narrative Major Depressive Disorder (MDD) is a significant public health problem because current therapies fail to work in many patients. Interestingly, manipulations that increase the excitability of the dorsal hippocampus have been shown to limit behavioral changes in response to chronic stress, although it remains unclear why this is the case. In this proposal, we will investigate the role of a newly discovered pathway from the dorsal hippocampus to the nucleus accumbens, a region that has previously been implicated in behavioral changes following chronic stress.